Determinants of inception of inflammation in inflammatory bowel diseases

Project Summary
Crohn’s disease (CD) and ulcerative colitis (UC) affect over 2 million individuals in the United States and are
associated with considerable morbidity. Existing treatments achieve remission in fewer than 50% of patients.
Further, despite achieving endoscopic remission, up to 30% of patients with CD or UC will relapse over the
subsequent three years. Pathophysiologic mechanisms leading to relapse have not been well established. The
central premise of our proposal is that despite endoscopic, there exists a local pro-inflammatory microbial milieu
and transcriptional profile that favors disease relapse. We hypothesize that current clinical tools do not have
sufficient resolution to capture this state. Existing cohorts, by recruiting patients in a heterogeneous state of
active inflammation, cannot be used to infer mechanisms of loss of remission and inception of inflammation. A
targeted effort that comprehensively and longitudinally profiles a homogeneous cohort of patients in deep
remission is essential to define the dynamic relationship between microbial alterations, metabolomic,
transcriptional, and proteomic perturbations, and onset of inflammation. Identifying deficient components
favoring relapse also allows the development of intervention to replace these deficiencies, thereby extending
remission. They will also provide clues and serve as starting points for development of novel therapies. In the
first aim, we will recruit 300 patients with IBD in clinical and endoscopic remission and prospectively,
systematically follow them for 3 years. We will comprehensively characterize such patients through serial
sampling of mucosal and fecal microbiome, serum and fecal metabolome, and proteome in addition to detailed
environmental exposure assessment and measurement of drug pharmacokinetics. We will determine the
dynamic predictive utility of each of these parameters in defining future relapse from a state of quiescence. In
the second aim, we will define the role of pro-inflammatory changes at the cellular level by performing single cell
transcriptomic analysis from colonic and ileal biopsies in patients with quiescent CD and UC recruited as above.
This will provide important insights into loss of control of inflammation at the tissue level that determines future
clinical activity. The final study aim will train and validate a machine-learning predictive model to define the
contribution of each additional biologic layer to inception of inflammation and to identify more robust biomarkers
of a state of sustained remission. Defining the molecular basis of future relapse in patients in deep remission will
provide insights into the ‘pre-disease’ state, allowing for identification of immune pathways of relevance in
preventing disease. Defining the fundamental mechanisms through which disease inception occurs from
quiescence is critically important to inform key steps in the pathogenesis of these complex diseases, which in
turn, will offer opportunities for targeted mechanism-driven interventions to aid durable maintenance of remission
and health. The approaches and analyses outlined also have broad applicability to other autoimmune diseases.

Public health relevance
Project Narrative Despite achieving remission, up to 30% of patients with Crohn’s disease (CD) or ulcerative colitis (UC) will relapse over the subsequent 3 years. The mechanisms of sustained remission have not been defined. We propose a targeted effort that comprehensively and longitudinally profiles a homogeneous cohort of patients in deep remission to define the dynamic perturbations resulting in the inception of inflammation in quiescent disease.